Long Term Effectiveness of Uterine Sparing Fibroid Treatments

The lifetime cumulative incidence of uterine leiomyomas (fibroids or UF) is >80% among Black women and
~70% in White women. UF are the most common reason for hysterectomy in the U.S. and can cause heavy
menstrual bleeding requiring blood transfusion(s), pelvic pain, urinary and bowel problems, infertility, and
substantial impairment of quality of life (QOL). While alternatives to hysterectomy are available including
myomectomy (fibroid removal), uterine artery embolization (UAE), endometrial ablation (EA), and
radiofrequency ablation (RFA), there are significant knowledge gaps that preclude the development of
evidence-based clinical guidelines to select an appropriate UF treatment. Prior studies of UF treatments have
several key deficits including limited follow-up time (<2 years) and failure to assess important confounders,
such as pre-procedure fibroid characteristics, baseline QOL, and pregnancy intention. Two multisite registries
with harmonized data, COMPARE-UF (Myomectomy, EA and UAE patients) and ULTRA (RFA patients), have
the capacity to address critical evidence gaps and significantly improve care for women with UF.
This project will be led by COMPARE-UF/ULTRA investigators (MPIs) and extend the follow-up of 700
COMPARE-UF and ULTRA participants who have had a uterine-sparing fibroid treatment for up to 10 years
after the index procedure. Long term follow-up through menopause is critical to assess the durability of
symptom improvement and the rates of hysterectomy or other uterine procedures following the index
treatment. Currently, women in COMPARE-UF/ULTRA are followed only for 1-3 years post treatment; the
additional follow-up in this proposal, will have a major impact on clinical decision-making, provide relevant data
in a racially diverse (>40% Black) population, and include detailed imaging information (UF size, number and
location), and self-reported desire for future fertility obtained prior to the index fibroid treatment. Among women
who have undergone one of four uterine-sparing procedures (myomectomy, EA, UAE and RFA), validated
questionnaires from pre-procedure will be repeated annually up to 10 years post-procedure, to achieve the
following: Aim 1: Compare changes in fibroid symptoms and quality of life from pre-procedure up to 10 years
post-procedure among four uterine-sparing procedures: myomectomy, EA, UAE, and RFA. Aim 2: Compare
the rate of and time until treatment failure up to 10 years after the index treatment among participants who had
myomectomy, EA, UAE, and RFA. Aim 3: Identify baseline factors that predict clinical effectiveness after
myomectomy, EA, UAE, and RFA and with patient and provider input, create a clinical prediction tool (Fibroid
Treatment Calculator) that supports informed decision-making. Our preliminary data demonstrate ongoing
active engagement of these participants. This project is a time-limited opportunity that uses two well-designed
longitudinal cohorts with comprehensive baseline information collected with validated questionnaires and will
yield results for immediate application in clinical care.

Public health relevance
Uterine fibroids are common noncancerous tumors that can cause women to have severe bleeding, pelvic pressure and pain, urinary dysfunction, and adverse pregnancy outcomes. Although hysterectomy has traditionally been the most common treatment, many women seek alternative procedures that remove just the fibroid and preserve the uterus (myomectomy), leave the fibroids in the uterus but destroy fibroid tissue by heat (radiofrequency ablation) or by blocking blood flow (uterine artery embolization), or destroy the uterine lining to stop bleeding (endometrial ablation); however, there is no information on what happens to women after they have these treatments. Our goal is to study how well these hysterectomy alternatives improve fibroid symptoms and prevent the need for future fibroid treatment.